Mechanisms of amplification and nonlinearity in the mouse cochlea

PROJECT SUMMARY/ABSTRACT
Mammalian hearing sensitivity depends on the amplification of sound-evoked cochlear vibrations by outer hair
cells (OHCs). How these cells provide amplification across the frequency range of mammalian hearing remains
unresolved. This limits our ability to rehabilitate and eventually restore what is missing in ears with OHC
damage, which is a common cause of hearing loss. While amplification has been proposed to result from the
OHCs’ ability to change length and generate force, multiple sources of low-pass filtering are thought to
attenuate this motile response at high frequencies. It is therefore uncertain if OHC motility can work fast
enough to provide high-frequency force generation on a cycle-by-cycle basis. Additionally, recent observations
of large, sustained OHC length changes during sound stimulation suggest that these tonic responses may
serve as an alternative mechanism for modulating high-frequency vibrations, possibly by altering OHC
stiffness. However, the functional relevance of such tonic responses has yet to be tested. To study cycle-by-
cycle and tonic OHC motility in vivo, we will use optical coherence tomography to measure vibrations of the
OHC region in the mouse cochlea. Preliminary data from the cochlear apex supports the central hypothesis
that OHC motility can indeed provide high-frequency, cycle-by-cycle amplification in spite of low-pass filtering,
and that slow or tonic OHC length changes do not play a significant mechanical role. Here, we will test this
hypothesis more definitively by examining vibrations from the base of the mouse cochlea, which responds to
very high frequencies. In Aim 1, we will determine whether sound elicits fast OHC length changes in the
cochlear base and assess how these responses are shaped by low-pass filtering. Our hypothesis predicts that
sound will cause large OHC length changes at the requisite high frequencies, even if the responses are low-
pass filtered. In Aim 2, we will test whether tonic OHC responses play a role in regulating high-frequency
cochlear vibrations. Since direct observation of tonic OHC length changes may be constrained by the stiffness
of the basal cochlear partition, the strength of tonic responses will be inferred from the presence of vibratory
distortions that are thought to be generated by the same underlying nonlinear processes. OHC length will then
be slowly, acoustically modulated in order to test whether slow and/or tonic length changes influence vibrations
at higher frequencies. Regardless of the strength of any observed or inferred tonic responses, our hypothesis
predicts that slowly modulating OHC length will have little effect on high-frequency vibrations. Pursuing these
aims will reveal how OHCs operate in their natural mechano-electrical environment and identify the
mechanisms underlying high-frequency hearing sensitivity. The knowledge gained may inform future efforts to
develop novel rehabilitative strategies and regenerate functional, amplifying OHCs.

Public health relevance
PROJECT NARRATIVE Our ability to detect and discriminate quiet sounds depends on a mechanical amplification process that is mediated by the cochlea’s sensory cells. The goal of this project is to determine whether these cells can amplify responses to high-frequency sounds by rapidly changing length and generating force, or if alternative mechanisms are involved, such as slow or sustained changes in cell length that modulate how the surrounding structures vibrate. The knowledge gained will clarify how healthy ears work and what is missing in impaired ears, and will inform future efforts to rehabilitate and restore hearing.